Collaborative Oncology: Preparing for a Multisite Trial to Facilitate Communication between Radiation Oncologists and Radiologists in Cancer Treatment Planning and Surveillance

Project Summary
Radiotherapy (RT) planning systems are typically inaccessible to providers outside the RT department, making
comprehensive sharing of RT targets a challenge. Many radiation oncologists (ROs) and radiologists feel that
more collaboration is needed in both the pre-treatment planning and post treatment follow-up setting.
Elimination of prevalent systemic barriers that currently limit collaboration between ROs and radiologists
represents a low-cost, high-impact opportunity to improve cancer care delivery for the estimated 1 million US
patients who receive RT each year. Improved communication could enhance RT target accuracy and reduce
avoidable treatment toxicity, while also improving the efficiency and accuracy of post treatment imaging
interpretation. Ultimately improved communication between providers has the potential to lead to improved
locoregional cancer control, and beneficial impacts on patient stress and anxiety. Our multidisciplinary team of
ROs, radiologists, and care delivery researchers developed the novel CORRECT workflow (Collaborative
Oncology, between Radiologists and Radiation oncologists for the Evaluation of Contoured Targets) to enable
efficient sharing of RT plans with diagnostic radiologists for input on accuracy of RT targets prior to treatment
initiation. In our single site pilot trial, CORRECT facilitated communication between ROs and radiologists and
led to substantial changes in treatment targets for 46% of reviewed lung cancer cases. Our pilot trial was
promising but we need key information to inform a multi-site efficacy trial in collaboration with the Wake
Forest NCI Community Oncology Research Program Research Base (WF NCORP RB). Specifically, we
need to better understand: 1) feasibility of an updated workflow at community practices with varying usual
patterns of RO-radiology collaboration for RT planning, 2) RO and radiology perspectives on barriers and
facilitators to participation in the future trial, and 3) stakeholder preferences for key design features of the
future trial. Community oncology practices may experience challenges in engaging radiology partners for
research, thus it is critical to understand barriers and facilitators of provider engagement in future trials and
ensure our promising feasibility and utility findings translate to community settings. To support the planning of a
future Phase III multi-site efficacy trial of CORRECT to improve locoregional cancer control, we propose three
Specific Aims. In Aim 1, we will determine feasibility and acceptability of CORRECT at 4 NCORP practices with
varying RO-radiology collaboration for RT planning. In Aim 2, we will utilize semi structured interviews of ROs
and radiologists to evaluate facilitators and barriers to RO-radiology research and clinical collaboration.
Informants will include providers who participated in Aim 1 and providers who responded to our pre-grant
survey indicating interest but with barriers to participation. For Aim 3, we will work closely with NCORP
stakeholders to develop the future multicenter cluster randomized efficacy trial to determine the impact of
CORRECT on locoregional cancer control outcomes, informed by data from Aims 1 and 2.

Public health relevance
Project Narrative Radiation oncologists treat cancer with radiotherapy (RT) by outlining targets on imaging scans, but these physicians typically do not receive formalized training in image interpretation to the same degree as board certified diagnostic radiologists. While radiologists are specifically trained in imaging interpretation, several systemic communication barriers limit their input during RT target design, or their ability to see what areas of the body have or have not been treated as they evaluate follow-up imaging studies. The development of tools that can improve interdepartmental communication, such as the CORRECT workflow, is a critical need that could enhance the accuracy of RT targeting and the quality of post treatment imaging interpretation.